Translational Biology Core

Core B is designed to provide support to the projects by standardizing common methods and resources, ensuring consistency and quantitative accuracy across the Program Project. Each service of the Core is relevant to and will be utilized by each project. The goals of Core B are six fold: Specific Aim 1: To provide a centralized repository of cell lines, media, and collected serum for each project. Specific Aim 2: To perform wide-field and conformal irradiation of small animals using preclinical and clinical radiotherapy systems. Specific Aim 3: To perform multimodal imaging of small animals using preclinical systems for positron emission tomography (PET), x-ray computed tomography (CT), and bioluminescence imaging (BLI). Specific Aim 4: To perform histopathologic analysis of tissue specimens collected from experimental animal models. Specific Aim 5: To perform quantitative analysis of imaging data collected through the other Specific Aims. Specific Aim 6: To provide statistical support to the projects of the P01.

Public health relevance
Core B, the Translational Biology core ofthis program project, provides support to the projects for maintenance and standardization of cell lines and shared resources, as well as in the execution of common methods including animal radiotherapy and imaging, histopathology, data quantitation, and statistical analysis. These are essential services that are common to all projects.